Development of antimicrobials based on principles of induced proximity

PROJECT SUMMARY
Small molecules have been classically developed to inhibit enzyme activity; however, new classes of small
molecules that endow new functions to enzymes via proximity-mediated effect are emerging. Most of these
chimeric molecules have been developed in the context of cancer. We propose to build chimeric molecules that
recruit the immune system to bacteria. These molecules will be formed by joining together binders of proteins of
the complement system and binders of bacteria and exhaustively characterized using biochemical, biophysical,
and cell biology experiments.
1

Public health relevance
PROJECT NARRATIVE We propose to develop a new class of heterobifunctional small moleculesthat can recruit proteins of complement pathway to bacteria. PHS 398/2590 (Rev. 06/09) 1 Continuation Format Page